Autism Screening in Childcare Settings

Early detection of autism spectrum disorder (ASD) facilitates early intervention, which improves lifelong
prognosis. Universal screening in the medical home during toddler check-ups is successful at detecting many
cases of ASD, yet uptake remains low, in part due to many barriers to successful ASD screening by
pediatricians, including limited time and resources during the well-child visits, and low confidence in the
screening process. In addition, underserved children from minority and low-income families are less likely to be
screened compared to their White and middle-class peers, exacerbating the known disparities in access to
early diagnosis and ASD intervention. The current proposal aims to expand beyond screening at pediatric well-
visits, by developing and evaluating novel strategies to successfully screen for ASD in childcare centers, where
many children spend more than 30 hours per week. Although there have been screening studies conducted in
childcare centers, the feasibility of routinely using this alternate setting has not been widely addressed yet, and
preliminary findings indicate that primary care strategies are not acceptable in childcare settings. Early
Childhood Education Providers (ECEPs) have extensive exposure to normative child behavior and many hours
of engagement with children, including many in underserved communities, enrolled in childcare. Thus,
engagement of ECEPs in toddler screening could present an opportunity for significant improvement in ASD
early identification and reduction of disparities in age of diagnosis and early treatment. However, there are
existing barriers to autism screening in childcare centers, including low parental acceptance, which is critical to
identify and address. Therefore, the goal of this pilot study is to explore barriers and facilitators of systematic
screening by ECEPs, including cultural hesitancy, and using the strategies identified, examine the performance
of the illustrated Modified Checklist for Autism in Toddlers, Revised, with Follow-Up (M-CHAT-R/F) paired with
the Ages and Stages Questionnaires in childcare centers. The specific aims are to: (1) utilize qualitative
methods (field observations and semi-structured interviews) with ECEPs to investigate organizational barriers
and facilitators for implementation of ASD screening in childcare setting, (2) utilize qualitative methods (semi-
structured interviews) with disadvantaged parents of children attending childcare centers to investigate familial
and cultural barriers and facilitators for parent engagement in screening for ASD in childcare centers serving
underserved families, and (3) pilot novel strategies for ASD screening in childcare centers, informed by the
qualitative findings, to evaluate agreement between parents and ECEPs, accuracy of childcare screening, and
acceptability of ASD screening in childcare centers. Results of this proposed study will directly address a gap
in universal ASD screening, particularly for underserved families. Screening in childcare centers provides a
complementary strategy to existing screening at pediatric well-visits, which will improve access of children from
all backgrounds to early interventions and supports, critical for improved outcomes.

Public health relevance
Although screening is a known strategy to facilitate early detection of autism spectrum disorders (ASD), screening during routine toddler pediatric check-ups is not universal. The current study will examine the feasibility of ASD screening in childcare centers, by exploring barriers and facilitators of systematic screening by childcare providers, and examining the performance of a widely used screening tool in this novel setting. Screening in childcare centers represents an important complementary strategy to increase access to early ASD screening, particularly for underserved children.